NUTRITIONAL ASSESSMENT AND INTERVENTIONS FOR HIV INFECTED INFANTS AND CHILDREN

The objectives of this research plan are: to determine and validate body compo- sition measurements in HIV-infected infants and children. Longitudinal deter- mination of energy expenditure with HIV disease progression. To determine the effect of megestrol acetate on growth and nutrition of HIV-infected children with mild to moderate malnutrition in a double-blind, rendomized, placebo- controlled trial.